A Regulatory Cascade that Controls Pneumococcal Capsule Biosynthesis

Project Abstract
Streptococcus pneumoniae is one of the world's most debilitating human pathogens, and in the US is the most
common cause of community acquired bacterial pneumoniae, despite having an available vaccine. As the
vaccine can only contain some of the strains needed for immunity, we must find alternative treatments that
target all 93+ different versions (or serotypes) of this deadly pathogen. One of the largest problems in
pneumococcal research is understanding how this pathogen can quickly convert from a harmless nasal
commensal to invasive pathogen. Key to understanding this crucial transition is the regulation of one of S.
pneumoniae's most important virulence factors, the protective polysaccharide (sugar-based) capsule it uses to
avoid our immune system.
Our lab has now identified a crucial set of proteins that work together in S. pneumoniae, and based on their
high conservation likely many other pathogens, to enable invasiveness and disease. We have named the
collective proteins and small molecules that regulate this process the Capsule Regulatory Cascade, or CRC. In
this work we will elucidate how the CRC enables S. pneumonaie to invade the lung by understanding the
molecular and cellular interactions of this signaling network. Our methods to achieve this goal will include
looking at the CRC at the smallest level (atoms), through visualization of its action within whole live animals in
real time. Results from our studies will give unprecedented insight as to how this pathogen uses the CRC to
cause disease, paving the way for novel therapeutic strategies targeting all serotypes rather than just the
subset contained in the current vaccines. Finally, the CRC shares homology with proteins in humans that are
crucial regulators of human disease, such as cancer, cardiomyopathy and epilepsy. We thus predict that our
data will lend valuable insight into the mechanism by which these and other human diseases manifest.

Public health relevance
Project Narrative Streptococcus pneumoniae is one of the most problematic pathogens in the US, negatively affecting the morbidity and mortality predominantly of children under the age of five and the elderly. We have discovered a system we call the Capsule Regulatory Cascade (CRC) that enables this pathogen to become invasive and cause disease, and predict that by understanding the mechanism of the CRC we will be able to rationally design new inhibitors to prevent S. pneumoniae virulence. Furthermore, because the CRC contains elements that strongly resemble many human proteins known to cause cancer, cardiomyopathy, epilepsy and a variety of other diseases, we hypothesize that by understanding how the bacterial (S. pneumoniae) CRC works, we can use this information to then, in turn, understand how mutations within the human CRC versions result in the onset of these specific genetically encoded illnesses.